Probing structural and biophysical mechanisms of mitochondrial membrane ultrastructure

PROJECT SUMMARY/ABSTRACT
Organelle morphology is specialized for the highly adapted functions found in complex tissues. Mitochondrial
ultrastructure is exquisitely tuned to metabolic and physiological state. Abnormal morphology is a hallmark of
neurological disorders, cardiac conditions and cancer. With the cryo-EM `resolution revolution', we have
developed dramatic new understanding of membrane protein structure and regulation, but our knowledge of
organelle structure lags behind. This is due to the pleomorphic nature of organelles, and the challenge of
assigning specific morphological features to protein states. The overarching goals of my lab are to understand,
at a mechanistic level, how protein conformational change is influenced by subcellular context, how membrane
ultrastructure is regulated by protein factors, and the functional interplay of these elements in physiology and
disease. Over the next five years, my group will develop a technical platform that combines electron cryo-
microscopy (cryo-EM) and biophysical methods to study mitochondrial ultrastructure and its regulation. We will
apply our recent developed in vitro reconstitution systems to visualize reconstituted membrane proteins in
liposomes and bilayers by single-particle cryo-EM. We will mature our newly established electron cryo-
tomography (cryo-ET) pipeline for computational analyses of membrane properties to understand their
dependence on protein-protein interactions. We shall develop new structural and biophysical methods to
characterize organelle lipid heterogeneity. And finally, we will explore assembly or protein complexes in native
contexts. Together these approaches will advance mechanistic understanding of protein conformational state
and help us identify the fundamental determinants of organelle shape. We are broadly interested in questions
of membrane spacing, composition and curvature. We will develop tools precisely tailored for these questions
using mitochondria as a test bed, exploring the structure and function of candidate factors that regulate
mitochondrial membrane morphology, which play causal roles in neurodegenerative conditions. Opa1 is the
inner-membrane fusogen and cristae remodeler mutated in Dominant Optic Atrophy. SLC25A46 is an outer-
membrane member of the solute transporter family that plays important roles in coordinating lipid homeostasis
in Leigh Syndrome. MICOS is the stabilizer and regulator of cristae junctions (the `choke-point' to the
mitochondrial inner-membrane folds) whose loss results in early-onset fatal mitochondrial encephalopathy with
liver disease. This project's immediate impacts include sharing new models to understand mitochondrial shape
with cell biologists, equipping pharmacologists with new, highly specific conformational targets for therapeutic
development, and providing physiologists with fundamental rules for understanding tissue specialization. The
long-term goal is to build an extensible approach generalizable to other organelles, and a foundation for
rational control of organelle morphology from first principles.

Public health relevance
PROJECT NARRATIVE Mitochondria are organelles at the nexus of cell functions (energy production, calcium signaling, metabolism and programmed cell death) central to cancer, cardiac health and neurodegeneration. The interplay between protein structure and membrane shape is fundamental for understanding the principles of organelle morphology that lie at the heart of mitochondrial function. We will explore questions of protein structure, membrane environment and sub-cellular ultrastructure to develop an integrated program that explores central questions of organelle shape.